Optimizing Wolbachia-based interventions to ensure effective and equitable prevention of arboviral infections

PROJECT SUMMARY/ABSTRACT
Arboviruses, viruses spread to humans through the bite of infected arthropods such as dengue, Zika,
and chikungunya, represent an immense and growing burden to global health. The endo-symbiotic
intra-cellular bacterium Wolbachia is a novel form of disease control that has been shown to
successfully decrease the transmission of several arboviruses. Wildtype Aedes aegypti population
replacement can occur after releases of transinfected female Ae. aegypti mosquitoes, driven by
cytoplasmic incompatibility and maternal inheritance. Once Wolbachia introgression reaches a
predetermined threshold (~50-60% prevalence), population replacement can be sustained without
additional releases and reductions in arboviral transmission can be observed. However, successful
delivery of Wolbachia release interventions require an understanding of the factors that drive
introgression speed and stability and strategies that enable efficient implementation in a diverse
range of urban environments. Achieving rapid, sustained Wolbachia introgression remains
challenging in complex urban settings, particularly in areas with high arboviral burdens and
socioeconomic disparities, such as Rio de Janeiro. My preliminary research has identified that the
ratio of release doses to existing Ae. aegypti abundance predicts introgression success, and
calibrated high-dose releases have demonstrated promising results. This study leverages these
findings and unique data from Wolbachia release programs in Rio de Janeiro and Belo Horizonte,
Brazil to address critical barriers to equitable, efficient, and effective implementation of Wolbachia
interventions. Specifically, the proposed study aims to: (1) develop a statistical and mathematical
models to identify factors influencing introgression speed and optimal Wolbachia release timing and
dosing strategies based on comprehensive data from Rio de Janeiro and (2) empirically test the
effects of release doses on the speed of Wolbachia introgression utilizing data from experimental
releases in Belo Horizonte. By combining advanced modeling and real-world experimental data, this
research will identify scalable, efficient, and equitable strategies for Wolbachia interventions. These
findings will enhance global efforts to combat dengue and other arboviral diseases in diverse urban
contexts.

Public health relevance
PROJECT NARRATIVE Release of Wolbachia-infected Aedes aegypti mosquitoes has been demonstrated in a randomized controlled trial to be effective in preventing dengue and other arboviral infections. However, successful scaling of this intervention requires addressing key questions on the timing and dosage of Wolbachia-infected mosquito releases, particularly in impoverished communities where arboviral disease burden is greatest. My proposal addresses these questions by developing mathematical models aimed at identifying optimized intervention parameters and then empirically validating simulated outputs in real-world field experiments, which ultimately will provide critical evidence to inform the efficient and effective global roll-out of Wolbachia-based vector control.